Human Epilepsy Genetics - Neuronal Migration Disorders

Project Summary/Abstract:
Developmental brain malformations are at the core of significant neurological diseases affecting many
families in the United States and around the world. Epilepsy, specific learning deficits and intellectual
disabilities, cerebral palsy, and abnormalities of brain size can often be attributed to pathological malformations
of the cerebral cortex. Although symptoms such as epilepsy and intellectual disabilities may appear broadly in
the population for any number of reasons, our focus on those cases associated with cortical malformations
highlights individual developmental pathways likely represented by innumerable and rare Mendelian alleles.
Our lab has uncovered dozens of genes associated with these conditions, and we are beginning to dissect the
mechanisms underlying early cortical development. However, we know many more genes are yet to be
discovered and these currently unidentified genes will provide even more important insight into brain
development and function.
The goal of our research is to identify novel genetic factors that result in abnormal human cerebral
cortical development. This is achieved through 1] ascertaining families with congenital brain malformations,
presumably due to inherited factors, and categorizing conditions using neuroimaging data, 2] identifying the
genes that harbor mutations that cause the malformations, and 3] describing the function of these genes. We
focus on the Middle East for ascertainment of families, where the prevalence of intra-familial marriage and
large family size enriches this population for rare Mendelian disorders and offers significant power to study
even noncoding mutations, which are typically more difficult to characterize. Causative mutations are identified
using whole exome sequencing or whole genome and RNA sequencing when the mutation is not exonic. The
mutated gene is further characterized in cell lines, zebrafish, and mouse or ferret models in order to elucidate
its function.
The discovery of new genes, which when mutated result in abnormal brain development, impacts
human health in several ways. These discoveries 1] provide insight into classification and diagnosis of these
often devastating conditions that can be quickly translated to clinical practice, 2] permit improved genetic
counseling and testing for concerned families, and 3] offer an enhanced understanding of the underlying
molecular processes of the developing human brain which can inform the conception of potential future
therapies or interventions. These treatments may apply not only to our specific, often under-served, patient
populations, but also more broadly to numerous patients impacted by the relatively common symptoms of
seizures and intellectual and motor impairments. Hence, our research works to reduce the burden of
neurologic disease on our human society and does so with important short and long-term implications.

Public health relevance
Project Narrative: Human brain development is a complicated and poorly understood process and when something interferes with it, devastating problems like intellectual disability and epilepsy can result. Our goal is to better understand genetic disorders of human brain formation and growth, which we do by studying individuals with severe neurological symptoms and abnormal brain structure. Our results often provide specific genetic tests for families with affected children, provide insight into the normal pathways of brain development, and sometimes identify potential mechanisms to target for developing future treatments for some patients affected by these neurological conditions.